Integrated Cognitive Rehabilitation and Cognitive Behavioral Therapy Intervention for patients with Post-COVID-19 Cognitive Impairment and Depression

PROJECT SUMMARY/ABSTRACT
Research: The post-acute sequelae of SARS-CoV-2 infection (PASC) continues to pose an
unprecedented public health burden, and cognitive impairment (CI) and depression are among
the most common symptoms, which profoundly impacts functioning and quality of life. The
purpose of this study is to develop and pilot a novel intervention to treat post-COVID CI and
depression in patients with PASC by integrating two evidence-based interventions, cognitive
rehabilitation (CR) based on Goal Management Training (GMT) and cognitive behavior therapy
(CBT), and adapting the intervention specifically for ethnoculturally diverse patients with PASC.
The specific aims are to: 1) Develop a manualized intervention for diverse patients with post-
COVID CI and depression by adapting and enhancing a GMT CR+CBT approach and 2)
Determine the feasibility and preliminary efficacy of the intervention on diverse patients with post-
COVID CI and depression. To accomplish these aims, we will employ a mixed methods, design.
Qualitative findings from focus groups with patients with PASC will guide the development of the
intervention, which will be iteratively refined through additional semi-structured individual
interviews and evaluated for feasibility and preliminary impact in a pilot randomized controlled trial
(RCT). Candidate: The primary objective of this application is to support Dr. Jacqueline Becker's
career development into an independent investigator studying the bidirectional impact of cognitive
and mental health on chronic illnesses. Dr. Becker's proposed training activities are: 1) qualitative
methodology; 2) psychosocial intervention development; and 3) RCT design, implementation, and
evaluation. To achieve these goals, she has assembled a multidisciplinary mentoring team. Dr.
Wisnivesky, her primary mentor, is a health services researcher with expertise in PASC, health
disparities research, biostatistics, and RCT design and implementation. Her co-mentors include
Dr. Lin, a clinician-investigator with expertise in qualitative research and chronic disease self-
management in diverse adults, Dr. Feldman, a psychologist and expert in behavioral medicine
psychosocial interventions, Dr. Murrough, a world-renowned psychiatrist with expertise in clinical
trials for depression, and Dr. Bagiella, an expert in biostatistics and RCT design and evaluation.
Environment: The Icahn School of Medicine at Mount Sinai has a strong tradition of outstanding
research and the Department of Medicine is ranked 12th nationwide in NIH funding. The Division
of General Internal Medicine has a well-established research infrastructure with an exceptionally
strong record of successful and well-funded, mentored and independent investigators.

Public health relevance
PROJECT NARRATIVE The post-acute sequelae of SARS-CoV-2 infection (PASC) continues to pose an unprecedented public health burden, and cognitive impairment (CI) and depression are among the most common symptoms, which profoundly impacts functioning and quality of life. The goal of this study is to develop a disease-specific, culturally sensitive intervention integrating cognitive rehabilitation and cognitive behavior therapy to improve post-COVID-19 CI and depression in ethnoculturally diverse patients with PASC and to test its preliminary impact through a pilot randomized controlled trial. These findings will provide proof-of-concept for an integrated, evidence-based approach to treating two of the most common symptoms of a novel disease process and improve outcomes for a diverse patient population.